Role of Gs-alpha in central regulation of energy and glucose metabolism

We generated mice with disruption of Gs-alpha expression from the maternal allele in the central nervous system (mBGsKO) by mating females heterozygous for a Gs-alpha floxed allele with loxP recombination sites surrounding Gs-alpha exon 1 to males with a nestin promoter-cre recombinase transgene. Mice with similar loss of Gs-alpha expression in the central nervous system on the paternal allele (pBGsKO) were generated with reciprocal crosses. pBGsKO mice had normal survival and overall phenotype with no effect on glucose or energy metabolism or serum lipids as determined by multiple experimental approaches (body weight and composition, organ weights, serum chemistries and hormones, glucose and insulin tolerance tests, metabolic rate and food intake measurements). In contrast, mBGsKO developed severe obesity with diabetes, severe insulin resistance, and hypertriglyceridemia. The obesity began to develop after 5 weeks. Studies in younger mice indicate that the insulin resistance and glucose intolerance began to develop prior to obesity, indicating an effect on glucose metabolism independent of obesity. Further studies in mBGsKO mice showed that the obesity was primarily the result of reduced sympathetic nervous system activity and energy expenditure and reduced expression of brown adipose tissue genes associated with energy dissipation, such as uncoupling protein 1 (UCP1), with no primary effect on food intake. We hypothesized that mBGsKO mice may be defective the ability of the melanocortin system to stimulate sympathetic nervous system activity and energy expenditure. To test this hypothesis, acute food intake and energy expenditure responses to a melanocortin agonist (MTII) were measured. There were no differences between pBGsKO mice and controls, and there was little effect on the ability of MTII to inhibit food intake in mBGsKO mice. However, the ability of MTII to stimulate energy expenditure was markedly reduced in mBGsKO mice as compared to controls. Moreover mBrGsKO mice have impaired diet-induced thermogenesis and reduced heart rate and blood pressure. Overall these results confirm that Gs-alpha pathways in the central nervous system are critical regulators of metabolism and that maternal Gs-alpha mutations in mice (and most likely Albright hereditary osteodystrophy patients) results from Gs-alpha imprinting in one or more site in the central nervous system. In situ hybridization studies showed that Gs-alpha is imprinted in the paraventricular nucleus of the hypothalamus (PVN), a known site of melanocortin action and metabolic regulation. We more recently examined mice with loss of Gs-alpha in the ventral medial hypothalamus (VMH) using Sf1-cre and see no major effects on regular diet, but some resistance to diet-induced obesity. Mice with PVN-specific Gs-alpha deficiency using Sim1-cre (also loss of Gs-alpha in a couple of other sites) show very mild effects on energy balance and glucose metabolism, more prominent in males, but not to the extent as mBrGsKO mice. Unlike mBrGsKO, maternal PVN-Gs-alpha knockout mice show no defects in thermogenesis, indicating that Gs-alpha mediates thermogenic pathways in other brain regions.

We have studied mice with loss of Gs-alpha in glucose-excitable POMC (proopiomelanocortin) neurons. Results show them to be hyperglycemic with reduced insulin levels, suggesting a defect in central glucose sensing leading to a insulin secretory defect from pancreatic beta cells. There are appears to be no autonomous defects in beta-cell function. These mice are also hypocortisolemic, presumably due to the fact that the ACTH (adrenocorticotropin) neurons (which are also POMC neurons) lack Gs-alpha and therefore cannot respond to CRH (corticotropin releasing hormone). Preliminary results with constitutively-active Gs-alpha mutants in POMC neurons show opposite effects on glucose metabolism (improved glucose tolerance)

We have most recently made other neuron or region-specific Gs-alpha knockouts using different transgenic-cre mouse lines and have ruled out several areas and neuronal cell-types, including the ventromedial hypothalamus, POMC neurons, interomediolateral horn of the spinal cord, as sites where Gs-alpha deficiency leads to obesity and/or glucose intolerance. Gs-alpha deficiency in the ventromedial hypothalamus protects mice from diet-induced obesity and leptin resistance in response to high fat diet. We are also knocking out Gs-alpha in specific brain regions by stereotaxic injection of AAV-cre virus into various brain regions of Gs-alpha floxed mice. Recent results show that Gs-alpha imprinting in the dorsomedial hypothalamus (DMH) strongly contributes to the parent-of-origin-specific effect on energy balance observed with Gs-alpha mutations and that melanocortin receptor 4-Gs-alpha signaling in DMH mediates the stimulation of thermogenesis and energy expenditure. In the paraventricular nucleus of the hypothalamus (PVN) Gs-alpha mediated melanocortins' cardiovascular effects but not its effects on food intake. More recent studies with homozygous deletion of Gs-alpha in DMH show this signaling pathway to play an important role in food intake regulation, energy balance, thermogenesis, cardiovascular regulation, and leptin signaling. Many of these effects, including the defect in food intake regulation, likely result from impaired leptin signaling.

We have also knocked out Gs-alpha in MC4R-expressing cells and confirmed that Gs-alpha signaling in these cells is critical for energy balance and that imprinting of Gs-alpha in a subpopulation of MC4R-expressing neurons leads to parent-of-origin-specific metabolic effects of Gs-alpha mutations. Complete loss of Gs-alpha expression in these cells also uncovers an important role of Gs-alpha signaling in regulation of food intake.

Using our various mouse models we have shown that the melanocortin 4 receptor mediates its physiological responses to inhibit food intake and stimulate energy expenditure through different G proteins, with Gs-alpha in the DMH and other sites being important to stimulate energy expenditure and thermogenesis. Both moue studies and signaling assays of mutant MC4R receptor associated with human obesity suggests that the MC4R actin in the paraventricular nucleus of the hypothalamus on food intake is mediated by Gq/11 rather than Gs.